Community Engagement and Dissemination Core

SUMMARY-COMMUNITY ENGAGEMENT and DISSEMENATION CORE
The UNM Center for Native American Environmental Health Equity Research addresses emerging tribal
environmental health disparities associated with trash burning and dumping, resulting from insufficient
infrastructure disparities to manage solid waste on tribal lands. The Community Engagement and
Dissemination Core (CEDC) leverages established relationships among academic and tribal partners
(Cheyenne River Sioux Tribe, Crow and Navajo Nations) in support of tribal environmental health equity. The
CEDC expands sustainable, culturally-informed practices to enhance EH literacy, increase tribal EH research
capacity, foster community engagement in EH research, and implement multi-directional translational
strategies for disseminating the Center’s research. To enhance EH literacy, foster engagement in research
projects and build tribal EH research capacity, the CEDC will conduct regular location-specific EH symposia
and an ongoing webinar series covering such topics as incorporating traditional ecologic knowledge (TEK) into
the research process; environmental, biological and social determinants of health; collection and quality control
of environmental and survey data. The CEDC will seek collaboration from the community to 1) refine strategies
to support environmental sampling (e.g. identifying locations and frequency of trash burning activities for
monitoring micro-plastics and chemical exposures in environmental media), and participant recruitment for
surveys, 2) identify and support research liaisons, and 3) identify and support promising pilot project topics and
community collaborators. In response to community concerns, and lack of data, a survey of social stressors
and resilience factors is included as a CEDC activity in all tribal communities. Also in response to community
needs, implementation of a targeted environmental health and toxicology literacy education program will be
continued in the CEDC. Community research liaisons, hired exclusively from tribal communities, will
understand of environmental exposure sources and pathways based on local TEK, and transgenerational
perspectives on health and resiliency. The liaisons will assist with collection of environmental samples
including placement and collection of stationary wristbands and plant samples as citizen scientists. They will
conduct outreach, collect survey data and support research dissemination. Traditional Ecological Knowledge
(TEK)/Indigenous Way of Knowing (IWK) influence decisions regarding participation in research, especially
projects that involve the collection of information that has implications for others in the community. To facilitate
the linkage with TEK/IWK, our artist-in-residence will continue to develop art pieces (e.g. paintings) to translate
the Center’s complex scientific research objectives and findings to tribal communities using traditional
messaging relayed through native symbolism, storytelling, and other transgenerational imagery.